Equipment Supplement for R35GM140753: Enabling Whole Protein Dynamics Deep Learning Models

Project Summary not required, refer to:
NOT-GM-22-017: Notice of Special Interest (NOSI): Administrative Supplements for Equipment
Purchases for Select NIGMS-Funded Awards (nih.gov)

Public health relevance
Project Narrative not required, refer to: NOT-GM-22-017: Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for Select NIGMS-Funded Awards (nih.gov)